Identifying Modifiable Factors that Affect Veterans At-Risk due to Social Determinants of Health and Psychological Distress Access to Care Within Integrated Primary Care Settings

Background: Veterans are more likely to report psychological distress, which also elevates their risk for
certain social determinants of health, such as unmet social needs (e.g., housing instability). As the entry point
for most Veterans into care, the presence of multidisciplinary members on integrated Patient Aligned Care
Teams (PACTs) in primary care, such as social workers and Primary Care Mental Health Integration (PCMHI)
providers helps to address the wholistic needs of these Veterans by providing increased access to additional
resources that have found to improve patient outcomes. Significance: However, prior research has showed
that these integrated PACTs continue to demonstrate significant variation in meeting the needs of Veterans
with psychological distress and unmet social needs (even with the skillsets brought to the PACT by the new
members) leaving opportunities to improve access. Due to the negative impact of the comorbid experience of
psychological distress and unmet social needs on Veteran’s health on health, identifying ways to optimize
access to care within these integrated PACTs is an opportunity to reach a broad array of Veterans. Innovation
and Impact: The proposed research is innovative through its attention to an underdeveloped area of the
healthcare structure, integrated PACT characteristics, and its relationship with access. Informed by prior PACT
implementation literature and a conceptual framework on patient navigation, integrated PACT characteristics
include: structural, provider-specific, and team behaviors. Our aims seek to use mixed methods to provide
a comprehensive understanding from multiple perspectives on PACT characteristics predictive of improved
access and identify associated processes to achieve access within integrated PACTs within this high need
population. These results will provide immediate guidance to VHA on the types of evidence-based
interventions that can be utilized and practice changes that may support those interventions in achieving
access to care for Veterans with unmet social needs and psychological distress. Specific Aims: Aim 1 will
identify integrated PACT characteristics (provider, structural, and team behaviors) that significantly
predict initial engagement to care among Veterans with unmet social needs and psychological
distress. Hypothesis: Integrated PACT structural, such as staffing, and team behaviors, such as team meetings
will be the strongest predictors of initial Veteran engagement in care. Aim 2 will identify best practices and
perspectives from members and administrators within high performing integrated PACTs on ways to achieve
optimization of significant integrated PACT characteristics supporting high levels of engagement among these
Veterans. Aim 3 will test a model of hypothesized relationships between integrated PACT characteris tics and
access as measured by Veterans’ perceptions of care (perceived access), ratings of quality of care, and
engagement in care. Methodology: Aim 1 will combine data from two data sources (administrative data mixed
with integrated PACT (n=160) surveys) to identify which integrated PACT characteristics significantly predict
initial engagement, which will be defined as receipt of mental health or social resource care. Eligible Veterans
have recently been seen in primary care, report current psychological distress and the presence of at least one
unmet social need will be eligible. Aim 2 will use qualitative interviews to provide more in-depth information to
identify best practices and perspectives from high-performing integrated PACT members and administrators
(n=30). Aim 3 will use Aim 1 data and Veteran surveys (n=2000) to examine the role that Veterans’ perceptions
of care and quality of care play within the relationship between integrated PACT characteristics and
engagement in care using structural equation modeling. Steps/Implementation: Results will be shared via
traditional publications, but also directly with key stakeholders in primary care, who will utilize these results to
guide quality improvement projects. For instance, the results could help inform the PCMHI Competency
training efforts on various PACT characteristics when training new PCMHI providers.

Public health relevance
Many Veterans experience psychological distress that is further complicated by unmet social needs (e.g., housing/food instability) and seek care from VHA’s integrated Patient Aligned Care Teams (PACTs) in primary care. Although the VHA has integrated PACTs with additional resources by adding specific providers with specialized skillsets, such as social workers and Primary Care-Mental Health Integration providers, there is significant variability among integrated PACTs in Veterans’ access to care. This proposal builds upon this prior work and seeks to evaluate integrated PACT characteristics and their relationship with access within this Veteran population with complex needs. A noted gap in the literature, we aim to identify integrated PACT characteristics and processes that can be used to further optimize care for these complex Veterans. Another novel aspect of this research is its utilization of multiple sources of data to partner results obtained from the electronic medical record with surveys from PACT members’ and Veteran perspectives.